Antigen Specific T Cells

Project 3
Project Summary
Bone Marrow Transplant (BMT) has improved outcomes for patients with high risk or relapsed acute myeloid
leukemia (AML) and Myelodysplastic Syndrome (MDS). This is due to both the ability to give high doses of
chemotherapy and/or radiation to further eradicate residual leukemia and because the donor cells may detect
and lyse residual tumor cells, termed the graft-versus-leukemia (GVL) effect. However, patients with high risk
or persistent disease continue to experience a dismal prognosis despite BMT, ranging from 10-40% survival at
5 years. Thus, developing novel therapeutics for myeloid malignancies is critical. T-cell immunotherapy post
BMT using virus-specific cytotoxic T lymphocytes, has been highly successful for the treatment of virus-
associated diseases (including EBV+ lymphomas) after BMT. However, only limited studies have been
conducted utilizing T-cell therapies targeting non-viral tumor-associated antigens for patients after BMT. The
development of T-cells expressing a chimeric antigen receptor (CAR) for CD19 has shown significant promise
for patients with B-cell acute lymphoblastic leukemia (ALL). However, greater than 40% of the responses are
not durable because the tumor evades the immune system by downregulating or modulating expressed target
antigens. Furthermore, this approach can only target tumor antigens expressed on the cell surface and many
tumor-associated antigens (TAAs) are intracellular. Furthermore, to date, CAR-T-cell therapy has not been as
successful clinically for patients with myeloid malignancies as CD19-CAR T cells have been for patients with
ALL. To extend T cell therapy to patients with AML/MDS post allogeneic BMT, we have developed a novel
strategy to reactivate and expand T cells with specificity for multiple TAAs: Survivin, PRAME and WT1, which
collectively are expressed by >90% of myeloid blasts. We reason that targeting multiple TAAs simultaneously
will minimize tumor immune escape. Interest in BMT is also building as a potential means to clear HIV-1-
infected cells from infected persons and achieve a functional cure of HIV infection. However, interruption of
ART post-transplant is associated with life-threatening HIV rebound. Therefore, we propose that reconstitution
of the immune system early post-BMT with the adoptive transfer of ex vivo expanded TAA and HIV-specific T
cells carrying the CCR5Δ32 mutation would confer protection from relapse AND could reconstitute an effective
HIV cellular immune response to prevent such uncontrolled rebound. Our central hypotheses are: (i) that the
GVL effect post BMT will be enhanced by adoptive transfer of T-cells targeting multiple TAAs and (ii)
that this approach can be applied to HIV-associated malignancies and will be effective for targeting
multiple HIV and tumor associated antigens. We will test these hypotheses in clinical trials proposed for
Aim 1. In we will generate and infuse T-cell products from eligible BMT donors that target multiple TAAs (+/-
HIV) to HIV+ and HIVneg patients with AML/MDS. In Aim 2 we will evaluate the anti tumor and antiviral clinical
and immune responses after T cell infusion. In summary, this approach may enable T-cell immunotherapy to
become more broadly applied to all patients with malignancies after BMT.

Public health relevance
Project Narrative We have developed a “personalized” medicine to treat high risk HIV+ and HIVneg patients with acute myeloid leukemia (AML) after bone marrow transplant (BMT) by taking immune cells (T-cells) from donor blood, and training them to kill leukemia (+/- HIV). This project will test whether T cells specific for multiple tumor (+/- HIV) proteins can be generated and infused to prevent relapse after BMT. We believe that this novel approach will be safe and effective therapy for HIV+ and HIVneg patients with AML and ultimately for other cancers.